BIOLOGY OF INSULIN RECEPTORS IN GLOMERULAR CELLS

We propose to study insulin specific binding on glomeruli from mice and humans. Binding of insulin to mesangial cells from normal transgenic mice, and human kidneys is being investigated. The nature of the receptor will be studied and elucidated.